BIOBEHAVIORAL RISK FOR CARDIOVASCULAR DISEASE

For over two decades, anabolic steriod (AS) abuse has been prevalent in the world of sport; moreover, it is well known that AS are quickly becoming an abused substance among adolescent males who use the drug to secure peer approval and/or enhance physical self-esteem. while the medical community originally highlighted liver dysfunction as the major negative side effect of AS use, it is now apparent that cardiovascular disorders may pose a more serious threat. Although research with humans suggets that AS constitute a cardiovascular risk due to their role in lowering high density lipoproteins, our recent work with testosterone proprionate (TP) reveals that AS may have an even more dramatic influence on cardiovascular disease due to biohavioral factors. Sepcifically, when TP was administered to monkeys (Macaca fascicularis) it led to increased aggression and a marked elevation in baseline heart rate. Two studies are planned in this project to extend our knowlede of how TP impacts behavior and the physiologic function of macaques. In study #1, animals (N = 24) will be housed in separate pens containing a mixture of steroid and sham control subjects. The purpose is to optimize the possibility of steroids influencing changes in social dominance. Also, this mixed arrangement more closely approximates human use. Another objective of this study is to further examine the effects of TP on baseline heart rate and to determine whether it alters blood pressure as well. After study #1 is completed, the control animals (N = 12) will enter study #2. These animals will be split into two groups, allowed to reach social stability given steroids or a sham control injection for 8 weeks, and then cannulated so that we can examine their cardiovascular and neuroendocrine profiles across a 24 hr period and in response to an acute stressor. Neuroendocrine data collected biweekly while animals are in their social groups should shed light on the ecological validity of the cannulation procedure.